Development of a Highly Accurate Wrist/Ankle-Mount Non-invasive Blood Pressure Monitor for Neonatal Patients

SUMMARY/ABSTRACT
More than 340,000 neonates are admitted to the neonatal intensive care unit (NICU) each year in the United
States. Monitoring arterial blood pressure (BP) for them, particularly preterm low-birthweight newborns, can be
challenging. The oscillometric (OSC) brachial cuff is much less accurate in neonates than adults because it
derives systolic and diastolic pressures using population-based ratios. With lower BP, neonates as a group are
statistically underrepresented in these ratios, thus their BP measurements tend to be erroneous. The standard
method for neonatal BP monitoring is via the umbilical arterial catheter (UAC). However, UAC fails to work for
approximately 10% of patients when both umbilical arteries are damaged or regress after birth. For these
patients, there is no alternative available. UAC also carries significant risks including thrombosis, hematomas,
infections, and even death. To address this unmet clinical need of neonatal BP monitoring, JB HealthTech, Inc.
(JBH) is developing a highly accurate non-invasive BP monitor neoBPTM that operates in 3 modes. Its continuous
mode provides high-fidelity arterial BP waveforms similar to UAC, to derive arterial pressures, respiration rate,
and a suite of hemodynamic parameters. Its intermittent mode gives a convenient BP snapshot and heart rate,
similar to OSC. Its periodic mode runs at predefined running/resting time intervals for any clinical needs in
between. neoBP is based on a volume clamp (VC) technology, which is advantageous over other technologies,
such as statistical modeling where neonates are underrepresented, less accurate devices with airbags only, and
cuffless devices depending on calibration with UAC or OSC for every use. Using a novel closed-form theoretical
framework without empirical elements, we dynamically build the patient-specific pressure-volume function and
solved a long-standing inaccuracy problem of the BP industry. We have implemented the innovative algorithms
on the prototype, initiated preliminary adult clinical testing, and filed three US patent applications. JBH has strong
engineering expertise in medical device development. We also have partnered with neonatologists and
cardiologists to benefit from their clinical experiences and insights. With this diverse, complementary team, we
will advance our device from prototype to practice. The tasks to take neoBP into the NICU include hardware
redesigns and rigorous clinical tests. In this Phase I SBIR project, we will build our second-generation hardware
and neonatal cuffs meeting product specification matrixes to run clinical tests. We will also validate the accuracy
of neoBP against the standard of care UAC to demonstrate its feasibility. A successful comparative study in the
NICU will be the milestone for the project to advance to Phase II. neoBP would be the first highly accurate non-
invasive BP monitor in the NICU, provide a simple and reliable way to measure BP for all neonates. With
accuracy comparable to UAC, neoBP will eliminate UAC-related complications and become an indispensable
tool in every neonatologist's armamentarium. In Phase II we will further test it in multi-center clinical studies,
resolve any clinical related issues, redesign it for manufacturability, and receive FDA 510(k) clearance.

Public health relevance
PUBLIC HEALTH RELEVANCE: As a clinical surrogate for end-organ perfusion, blood pressure (BP) is one of the most important vital signs, thus monitoring it accurately and continuously is crucial in the neonatal intensive care unit (NICU) for stabilizing vulnerable neonates in their first days of life. While the NICU standard invasive method umbilical arterial catheter (UAC) fails on some patients and has risks and complications, the non-invasive oscillometric (OSC) based brachial cuff is less accurate on neonates than on adults, therefore not suitable for critically ill neonates because they have lower BP and less tolerance for BP variability, which require stricter error specifications than the current industrial standards. neoBP will be the first non-invasive BP monitor that can replace both UAC and OSC in the NICU, with high accuracy of pressure errors within 3 ± 5 mmHg (mean error ± standard deviation), better than the ANSI/AAMI/ISO 81060-2:2013 standards of 5 ± 8 mmHg, which would set a new standard leading the BP industry and change how blood pressure is clinically managed today.